SPHERE (Survivorship Plan Health Record) Implementation Trial

PROJECT SUMMARY/ABSTRACT
The Institute of Medicine recommends that each cancer patient receive a survivorship care plan that
summarizes information important to the individual’s long-term care, including the following: (1) cancer type
and treatments, (2) their potential consequences, (3) recommendations regarding preventive practices, and (4)
specific information about recommended follow-up. Despite their clinical importance, gaps in CRC surveillance
care and preventive care exist among CRC survivors. Unmet symptom needs are also prevalent and
undertreated.
We propose to evaluate the capacity of an interactive survivorship care plan (SCP) delivered through an
Internet-based personal health record (PHR) to meet the needs of CRC survivors. PHRs combine health
information and medical data with knowledge management and software tools to potentially enable patients to
become active participants in their own care. A SCP delivered via an appropriately designed PHR may
promote increased concordance with CRC surveillance and preventive care guidelines through the exchange
of health information between CRC survivors and health care providers. A survivorship care plan-personal
health record (SCP-PHR) may also improve care for symptoms through the combination of longitudinal PHR-
based symptom measurement and tailored self-management tools. To understand the effectiveness of the
SCP-PHR, we will conduct a randomized clinical effectiveness trial at the patient level. We will assess impact
of the SCP-PHR across a variety of measures and outcomes, including CRC surveillance, preventive care
receipt, patient symptoms, and patient-centered quality.
To simultaneously understand the effectiveness and implementation of the SCP-PHR, we will conduct a hybrid
type I effectiveness-implementation trial consisting of the following components: (A) a randomized clinical
effectiveness trial at the patient level, and (B) a mixed methods implementation study. The mixed methods
portion of the study will consist of a quantitative evaluation of patient attitudes toward technology associated
with the frequency and patterns of SCP-PHR use, as well as a qualitative process evaluation using semi-
structured interviews to assess facilitators and barriers to implementation of the SCP-PHR among key
stakeholders: patients, health care providers, and organizational leaders. This study design will enable us to
meet the simultaneous needs of understanding the effectiveness and the health care context of SCP
implementation.

Public health relevance
PROJECT NARRATIVE To understand the effectiveness and implementation of the SCP-PHR, we will conduct a hybrid type 1 effectiveness-implementation trial consisting of the following components: (A) a randomized clinical effectiveness trial, and (B) a mixed methods implementation study.